Sex and racial/ethnic differences in B-ALL genomics

Project Summary
Children with substantial African ancestry have long been known to have half or less the rate of B-
cell acute lymphoblastic leukemia (B-ALL) than do children with other continental ancestries. Moreover,
AA children have lower incidence despite having greater exposure to many putatively causal environmental
risk factors for B-ALL than do white children. However, even within AA children, we still observe a 30% excess
incidence of ALL among males compared to females at all ages and a remarkable 300% increased incidence
at 12 years of age. The male excess may depend on sex-varying associations with the disease for germline
genetics on the autosomes and the X chromosome, sex differences in immune function, and/or hormonal
differences. Common genetic variants established by genomewide association studies (GWAS)
incompletely explain the deficit of B-ALL in AA children, suggesting undiscovered contributing genetic
factors may be detected by admixture mapping. Few studies examine GWAS by sex. The parent R01 of this
Administrative Supplement, titled “Admixture analysis of acute lymphoblastic leukemia in African American
children: the ADMIRAL Study” (R01 CA239701), includes existing DNA samples and data for 930 B-ALL
patients with AA ancestry and will accrue ~600 samples over the remaining project years. We are conducting
admixture mapping in the assembled group of patients to detect new genetic loci and new variants at
established loci associated with occurrence of B-ALL. In addition, we are examining admixture in association
with clinical characteristics at diagnosis and survival. Candidate genes/variants will be functionally evaluated
through both in silico and in vitro techniques. For the Administrative Supplement, we will conduct sex-stratified
GWAS in AA children with B-ALL from the parent R01 and we will expand our analyses to include the X
chromosome, which is generally excluded from GWAS. As part of this Award, we will generate a new source of
genomic data from healthy AA children using umbilical cord hematopoietic stem cells, which we will use to map
sex-differential expression quantitative trait loci for each sex thereby decreasing our search space for disease-
relevant loci and increase our power to identify biologically relevant loci in AA males and females with B-ALL.
Findings will be placed in context to those observed in AA children that we are currently generating as part of
our other funded research. The proposed research will potentially answer a long-standing mystery by revealing
critical genes or loci that may explain increased incidence of B-ALL in AA males. Identifying sex-varying
associations between germline SNVs and childhood ALL will allow us to identify biologic mechanisms
contributing to the observed sex differences in AA B-ALL incidence.

Public health relevance
Public Health Relevance African American (AA) children have half or less the rate of acute lymphoblastic leukemia (ALL) than do children of other ancestries yet AA males experience a 30-300% excess in incidence than females, depending on age. Building off of the parent R01 where we are conducting admixture mapping of ALL risk among AA children, we are proposing to conduct sex specific genomewide association studies using the same genomewide array data being generated by the parent grant, including the X chromosome, and we will identify sex-differential expression quantitative trait loci using a newly generated source of pediatric data for AA children. The proposed research will help us identify risk loci that vary in association with ALL by sex among AA children, who are often excluded from such studies, and may identify prevention strategies for future investigation.